Spatial-frequency decompositions for enhancement of source reconstruction resolution in MEG

Project Summary
Non-invasive imaging of brain anatomy and function is essential for the study of the development and
operation of the human brain. It provides clinicians with invaluable information on neurological conditions, both
in terms of understanding mechanisms of neurological diseases in general as well as providing guidance for
diagnostics and treatment planning of individual patients. Among all functional imaging modalities,
magnetoencephalography (MEG) has the best combined spatiotemporal resolution, which makes it an
excellent tool for neuroscience and neurology. To exploit the potentially good spatial resolution of MEG, one
must solve the inverse problem, i.e., estimate the underlying neural currents from the spatially discretized
measurement of the magnetic field. This task, which is non-unique in principle, is accomplished by fitting
specific parametrized mathematical models to the acquired multi-channel data and determining a set of
parameters that provides the best fit according to a particular optimization criterion. Consequently, these
parameters translate to an estimate of the spatial structure of the neural current, which is used in the
interpretation of brain function under various tasks and conditions. The spatial precision of MEG can be
determined by considering the following question: What is the minimum distance between two nearby spatial
concentrations of neural current that can be distinguished as two separate sources instead of one, perhaps
extended, source? In principle, this task appears increasingly more difficult as the distance between the
sources and the measurement sensors increases. The reason for the difficulty is two-fold: 1) the amplitude of
the magnetic field decreases with distance and 2) the spatially complex features of the magnetic field decay
with distance faster than the spatially smoother, less informative, features. In conventional inverse modeling,
the second type of difficulty may cause distinct sources to become merged as one estimated source even in
the hypothetical situation that the sensors have no noise at all. To improve fundamental resolution of MEG, we
will utilize our extensive expertise in hierarchical decompositions of magnetic signals by which we can separate
signal features corresponding to different levels of spatial complexity, represented as spatial frequencies. In
Aim 1, we develop new frequency-dependent hierarchical basis functions applicable to on-scalp
measurements as well, optimize the numerical stability of the decomposition of the corresponding frequency
components, and develop methodology for frequency-specific inverse modeling that aims at improving spatial
resolution with the help of high-frequency components. In Aim 2, we develop methodology for new sensor
array design in order to maximize the detectability of a wider frequency spectrum than what is achievable with
conventional MEG systems. We exploit the fact that new sensor technologies allow for flexible designs and
suggest subject-specific sensor placement optimization as well. In Aim 3, we design simulations, phantom
measurements, and human measurements to validate our methods.

Public health relevance
Narrative MEG has an excellent spatiotemporal resolution and it is an excellent tool for non-invasive study of normal brain functions as well as diagnosis of a large variety of neurological conditions including epilepsy, autism spectrum disorders, Parkinson’s disease, and Alzheimer’s disease. The spatial resolution of MEG is limited by the signal-to-noise ratio of brain-related magnetic fields but also the fact that the spatially smooth features of the brain signals dominate the measurements over the more fine-detailed components. This research will provide novel mathematical methods to extract and emphasize the fine-detailed field components, both in terms of mathematical modeling and design of novel MEG sensor array geometries.